Adapting an effective intervention for enhancing engagement in HIV care to meet the needs of key populations in India

PROJECT SUMMARY/ ABSTRACT
Progress toward UNAIDS testing and treatment targets has been slow in many global settings, including India,
where only 46% of the 2.1 million people who live with HIV (PLWH) are estimated to be virally suppressed.
This gap is especially pronounced among Key Populations (KP) who have much higher prevalence of HIV than
the general population, but lower rates of viral suppression, partly due to intersecting stigma. In this
application, we therefore seek to adapt and pilot test a comprehensive wellness program to address the
barriers to engagement in the HIV care continuum among men who have sex with men (MSM) and
transgender women (TGW) in India. The proposed adapted intervention is guided by a conceptual model that
integrates our India-specific HIV stigma model, which showed that stigma can delay care-seeking both directly
and indirectly, with the Minority Stress Model adapted for India by our Indian collaborator. The content
involves an adaptation of our earlier Chetana wellness adherence intervention which was found to successfully
improve adherence and viral suppression among mainstream Indian PLWH. Based on our initial formative
work, the adaptation includes added wellness group content and will be offered in a flexible format. It also uses
peer navigators (PN), rather than MA-level counselors, to deliver tailored support at mutually convenient times
and places. This PN model has been used successfully by our Indian collaborators and in our previous
research in South Africa to link and retain PLWH in care. The intervention is intended to break the link between
stigma and care seeking, which is especially important for KPs, who must deal with historically hostile legal
environments and substantial isolation that further reduces engagement in HIV preventive practices and
services. This application also takes advantage of India’s adoption of a universal test-and-treat policy, allowing
newly diagnosed KPs to be immediately engaged in HIV care, rather than having to wait until they meet CD4
eligibility criteria. Our Indo-US team has a long history of prior research collaborations as well as more than 20
years of work with key populations in this setting. We are thus uniquely positioned to conduct the proposed
research to address the following aims: 1) To engage community stakeholders in the adaptation and pilot
testing of the Chetana-PN wellness adherence intervention for use with Indian MSM and TGW who are living
with HIV and who are newly or insufficiently engaged in care. 2a) To assess in a small RCT the acceptability
and feasibility of the theoretically-guided, adapted intervention and to obtain preliminary effect size estimations
for the impact of the intervention on engagement in care, among MSM and TGW. 2b) To characterize
participant and navigator experiences in the Chetana-PN intervention and describe the practices that were
most successful at overcoming barriers to care with 25 participants who received the Chetana-PN intervention
and the peer navigators. These findings will subsequently be used to inform a future RCT designed to establish
the efficacy of this adapted Chetana-PN intervention for sexual minorities in India.

Public health relevance
Project Narrative In many global settings, key populations are more likely to be infected with HIV, but less likely to be virally suppressed than members of the general population living with HIV and research shows that this is at least partly due to the multiple stigmas that act as barriers to care-seeking, prescription refills and consistent consumption of their medications. The proposed study seeks to address this problem by adapting and pilot testing a culturally appropriate, comprehensive wellness program that incorporates peer navigation and is based on our previous work in India and South Africa, to improve engagement in HIV care among men who have sex with men and transgender women in India. If successful, the proposed low-cost strategies, tailored to the needs of sexual minorities, can improve both the health of the participants, decrease the likelihood of HIV transmission to their uninfected sex partners and be adapted for use in other global settings including the US.